Mechanisms of Inflammation Resolution in Bacterial Endophthalmitis

Project Summary Inflammation is generally considered a beneficial host response towards invading pathogens or tissue injury. Prolonged inflammation, however, can be destructive and maladaptive, leading to irreversible damage to delicate tissues. Thus, the ideal treatment approach when dealing with inflammation-sensitive tissues, such as the retina, should include immunomodulatory therapies to promote the rapid resolution of inflammation and the restoration of tissue homeostasis to minimize secondary host-mediated damage. Recently, pro-resolution- based strategies using specialized pro-resolving mediators (SPMs) have shown great potential for the treatment of multiple inflammatory diseases. We show that the intravitreal administration of resolvin D1 (RvD1), a type of SPM, in bacterial (S. aureus)-infected mouse eyes attenuated the development of endophthalmitis, with drastically reduced inflammation and tissue damage and preserved retinal function, underline the importance of RvD1-mediated pro-resolving signaling in endophthalmitis. However, unexpectedly, we discovered that RvD1 treatment failed to protect the eyes of Toll-like receptor 2 (TLR2) knockout mice from staphylococcal endophthalmitis. Moreover, we observed a direct interaction of TLR2 with the RvD1 receptor, lipoxin A4/formyl peptide receptor 2 (ALX/FPR2, referred as FPR2). This raises an interesting fundamental question, whether the molecule or signaling pathways that induce the resolution of inflammation interact with other pathways such as the TLRs, which promote the induction of inflammation. Thus, based on prior studies and our preliminary data, we hypothesize that RvD1-mediated protective innate responses in bacterial endophthalmitis are dependent on TLR2 signaling. This will be tested with three specific aims. Aim-1 will decipher the mechanisms underlying RvD1-induced protective innate responses in bacterial endophthalmitis. This will be accomplished by using pharmacological inhibitors of RvD1-mediated FPR2 signaling, as well as the use of FPR2 overexpressing transgenic (Tg) mice and FPR2 KO mice. Bone marrow chimeric studies will be performed to determine the relative contribution of FPR2 on residential vs. myeloid cells. Aim-2 will investigate the interplay of the RvD1 and TLR2 signaling pathways in promoting inflammation resolution in endophthalmitis. These studies will elucidate this novel cross-talk by determining 1) whether TLR2 deficiency alters the generation of RvD1, 2) under which conditions TLR2 and FPR2 interact physically, and 3) the consequences of this interaction on downstream signaling. Aim-3 is designed to test the efficacy of RvD1 as an adjunct therapeutic in mitigating endophthalmitis-associated vision loss. Proposed experiments include the co- administration of RvD1 with conventional antibiotics and the determination of the optimal route of delivery (topical vs. intravitreal) and a comparison of its efficacy with that of corticosteroids. Together, we believe that the mechanistic insights and the treatment strategies developed in this proposal could have a major impact on the field, not only with regards to endophthalmitis but other ocular and non-ocular infectious diseases as well.

Public health relevance
Project Narrative Bacterial endophthalmitis is a vision-threatening complication of penetrating eye injuries and intraocular surgeries, notably the cataract surgery, the most common ophthalmic procedure performed in older populations worldwide. As the aging population in the US grows exponentially, the number of cataract surgeries performed will also increase significantly, resulting in a proportional increase in the incidence of endophthalmitis. Studies in this proposal are designed to investigate the mechanisms to harness the therapeutic value of a lipid mediator, Resolvin D1 (RvD1), to potentially treat endophthalmitis and prevent blinding inflammation in the eye.